Cancer Research Training and Education Coordination

CANCER RESEARCH TRAINING AND EDUCATION COORDINATION: PROJECT SUMMARY
The goal of Georgetown Lombardi Comprehensive Cancer Center’s (LCCC) Cancer Research Training and
Education Coordination (CRTEC) component is to develop, implement, and sustain comprehensive cancer
research career development programming for participants at all career stages, from K-12 scholars to mid-career
faculty. CRTEC focuses on the needs of the individual, cutting-edge experiential learning opportunities,
implementation of evidence-based mentoring practices, and a deep commitment to building diversity, equity, and
inclusion into cancer research training and education across the LCCC Consortium. Notable for this funding
period are a new Associate Director (AD) for Education and Training, and full staffing of CRTEC with an
Administrator and Metrics/Analytics Coordinator. Across all three Research Programs; Community Outreach and
Engagement (COE); Diversity, Equity, and Inclusion (DEI); and the Consortium partnership, CRTEC has
collaboratively expanded training and career development programs. These include: (1) implementing the
evidence-based “Entering Mentoring” curricula to support best practices in mentoring and career development,
(2) creating “Diversity in Cancer Research” internship and career development program for underrepresented
minority (URM) undergraduates funded by the American Cancer Society, (3) creating a “Young Scholars
Program” for catchment area (CA) elementary school students to be introduced to cancer research, (4) receipt
of two new T32s and nine new K awards, and (5) creating tailored oncology research fellowships for medical
students. CRTEC has three Specific Aims, each focused on a specific phase of the training and career
development pipeline, and all are guided by the CRTEC Advisory Council using a robust process to evaluate
and optimize program efficacy and impact. Aim 1 develops and supports programs that encourage K-12 and
undergraduate students to explore careers in cancer research. Aim 2 enhances the multidisciplinary cancer
research training environment for graduate and medical students, residents, postdoctoral and clinical fellows.
Aim 3 provides a strong mentoring and career development structure for early to new midcareer faculty. During
the current funding period, LCCC has provided cancer training, education, and career development for 181 K-
12 and undergraduates, 94 PhD, MD, and MD/PhD students, 70 postdoctoral and 42 clinical fellows, and 42
early career faculty of which 23% are URM. Plans for the next project period include: (1) collaborate with COE
and DEI to develop signature training programs that better serve students in our CA, (2) increase grant-funded
training and career development opportunities for clinical investigators, and (3) recruit, support, and retain early
career URM faculty in cancer research.